PfAg, a multivalent peptide vaccine against malaria

ABSTRACT
PfAg is our novel malaria vaccine, composed of short synthetic peptides representing specific immunogenic epitopes of
the Plasmodium falciparum circumsporozoite (CSP) and Anopheles gambiae TRIO (Ag TRIO) proteins. Our prototype Pf Ag
has yielded outstanding early results, including immunogenicity to target antigens and to achieve sterile immunity in an
outbred heterogenous CD-1 mouse model. This Phase I feasibility STTR project aims to (i) optimize the prototype PfAg
vaccine construct and (ii) conduct efficacy testing to confirm the optimal construct design. Our long-term goal is to develop
a novel peptide-based vaccine that can be used alone as a multivalent CSP/AgTRIO vaccine or co-administered with
existing pre-erythrocytic vaccines such as RTS,S and R21 for a more robust immunological initial or boost response. Our
target customers include global health and government organizations calling on developing new tools to eradicate malaria.
A peptide-based vaccine's safety, production, and cost profile are favorable for addressing the real-world challenges of
deploying a vaccine in malaria-endemic, resource-poor countries, where the current malaria eradication approach is
limited by efficacy, cost, and logistics issues.

Public health relevance
NARRATIVE Nearly half of the world's population is at risk of malaria, with high rates of morbidity and mortality and significant social and economic costs. The introduction of the RTS,S, and R21 vaccines marks a considerable achievement; nevertheless, in light of the limitations of these vaccines, the World Health Organization, NIH/NIAID, and other health organizations recently emphasized the urgent need for complementary strategies such as new vaccine targets and approaches. This project will develop a synthetic peptide bivalent vaccine targeting protective antigens from both P. falciparum and A. gambiae -CSP and Ag TRIO, respectively-towards the long-term goal of a potent vaccine that provides robust protection against malaria for use in humans.